Auricular Neuromodulation in Veterans with Fibromyalgia: A Randomized, Sham-Controlled Study

BACKGROUND: In the setting of the opioid epidemic, it is crucial to develop and assess non-pharmacologic
treatments for pain and understand underlying mechanisms. In the present investigation, we assess a novel
non-pharmacologic approach to chronic pain treatment in veterans suffering from fibromyalgia (a notoriously
difficult to treat pain syndrome that affects 5-10 million Americans and disproportionately affects those
returning from the Gulf War), utilizing brain imaging as a biomarker and heart rate variability (HRV) to assess a
vagal mechanism. Preliminary results from our prior VA-funded feasibility study reveal a trend towards
improved pain and function with a FDA-approved, non-pharmacologic therapy - auricular percutaneous
electrical nerve field stimulation (PENFS) - over standard therapy control for veterans suffering from
fibromyalgia, correlating to altered network connectivity on rs-fcMRI (resting state functional connectivity MRI).
PENFS-related improvements continued through 12 weeks following the completion of treatment and
correlated to changes in cross-network connectivity, which differed between groups. Based on our preliminary
data, we now intend to rigorously assess the treatment effects of PENFS in a large, double-blind, randomized,
sham-controlled study. OBJECTIVE: The proposed Merit, a randomized, sham-controlled trial of auricular
PENFS, evaluates the clinical utility of PENFS for fibromyalgia as compared to sham placebo control, acute
and longitudinal PENFS-related neural changes visualized on rs-fcMRI and effects of PENFS on HRV as a
potential vagal mechanism of pain relief. HYPOTHESIS: True PENFS results in non-placebo-related short- and
long-term pain and physical function improvements that can be correlated with altered connectivity and HRV.
METHODS: For Aim 1, 240 total participants meeting 2016 diagnostic criteria for fibromyalgia (male and
female, age 18-60 years old) will be randomized to either true (n=120) or sham (n=120) auricular PENFS.
Neuroimaging data, self-reported pain, and physical function will be assessed at baseline and at 1- and 12-
weeks post-treatment to evaluate neural correlates of PENFS-related treatment. Participants who meet study
criteria will be randomized to either true or sham PENFS (series of 4, weekly) treatments and assessed for rs-
fcMRI and functional changes at 1- and 12-weeks post-treatment. Baseline and follow-up rs-fcMRI will be
utilized to identify biomarkers of fibromyalgia and PENFS treatment effects for Aim 2 in a subset of 62
participants from Aim 1 who qualify for MRI procedures. Cardiopulmonary data will be simultaneously collected
during rs-fcMRI and utilized for our exploratory Aim 3 to evaluate potential PENFS effects on HRV as an
outcome measure for vagal effects. In the initial phase preliminary analytical validation will be accomplished in
the first 30 participants following IRB approval, hiring and training of staff, and establishment of an image
processing pipeline. If initial milestones are met, the rigorous, double-blind, sham-controlled study in a larger
group of veterans will continue. Veterans who are initially assigned to sham placebo PENFS and are not
identified as placebo-responders will be offered the opportunity to test the true PENFS device. This study
addresses the critical need to clinically evaluate non-pharmacologic therapies for chronic pain.

Public health relevance
PENFS (percutaneous electrical nerve field stimulation) is an FDA-approved acupuncture-like therapy applied to the external ear targeting several cranial nerve branches including the auricular branch of the vagus nerve to improve pain, physical function, and reduce symptoms of opioid withdrawal. PENFS has been previously shown to provide improvements in fibromyalgia, a difficult to treat chronic pain syndrome, which correlate with changes observed using a special kind of MRI called resting state functional connectivity MRI (rs-fcMRI) that evaluates brain activity at rest. The goals of this study are to rigorously test the initial promising results of PENFS in a much larger group of veterans suffering from fibromyalgia and to identify potential mechanisms of PENFS effects. Further developing non-pharmacologic therapies for pain can help to improve quality of life and function for those suffering from fibromyalgia and decrease reliance on opioids and other drugs that have numerous side effects for individuals suffering from chronic pain.